North Carolina Diabetes Research Center

PROJECT SUMMARY/ABSTRACT – METABOLOMICS CORE
Comprehensive metabolic analysis, or “metabolomics”, is a technology that defines the chemical phenotype of
living systems. Given that metabolic fluxes and metabolite levels are downstream of genomic, transcriptomic,
and proteomic variability, metabolomics provides a highly integrated profile of biological status. As such, it has
unique potential for discovery of biomarkers that predict disease incidence, severity, and progression, and for
casting new light on underlying mechanistic abnormalities. Metabolomic analyses are challenging, however, due
to the complexity inherent in measuring large numbers of intermediary metabolites with diverse chemical
properties in a quantitatively rigorous and reproducible fashion. The DMPI Metabolomics Core Lab has a long
history of collaborative research and has established a strong and reliable infrastructure for conducting
measurements for investigators at Duke and at outside institutions. Thus, it is well poised to become the NCDRC
Metabolomics Core. While Duke has world-renowned facilities for metabolomics, its use by diabetes
investigators outside of Duke (such as WF and UNC researchers) has been limited by bottlenecks, particularly
in the analysis and interpretation of data, which the NCDRC seeks to address by establishing the NCDRC
Metabolomics Core with support from Research Navigators.